Unraveling the link between serine/threonine protein kinase and two-component system regulation of environment-mediated Mycobacterium tuberculosis growth arrest

PROJECT SUMMARY/ABSTRACT
A marked feature of Mycobacterium tuberculosis (Mtb) infection is heterogeneity that encompasses several
aspects, including in bacterial replication status and in the local microenvironment. This heterogeneity exists
not just temporally, but also spatially even within a single lesion, as revealed at the single bacterium level by an
integrated imaging system that combines the use of fluorescent reporter Mtb strains, a murine infection model
that recapitulates hallmark caseous necrotic lesions, and confocal imaging. While environmental signals such
as nitric oxide (NO) are known to be able to drive Mtb into growth arrest, how Mtb coordinates its replication
with environmental cue response remains largely unknown. Further, the interplay between the two key systems
that play central roles in Mtb signal transduction, namely serine/threonine protein kinases (STPKs) and two-
component systems (TCSs), is also poorly understood. To this end, we recently uncovered the essential
transcription factor PrrA, part of the PrrAB TCS, as (i) a regulator of Mtb response to multiple environmental
cues, including NO, and (ii) a TCS whose function is significantly modulated by STPK phosphorylation, with
consequent effects on Mtb replication status in response to NO. Aim 1 of this proposal thus seeks to elucidate
the global transcriptional impact of STPK regulation of PrrA on the adaptive entry of Mtb into a non-replicating
state upon extended NO exposure, utilizing a PrrA STPK phosphoablative mutant. A bacterial-two-hybrid
approach will further be undertaken to uncover the STPKs responsible for phosphorylation of PrrA. Aim 2
focuses on understanding the functional consequences of STPK regulation of PrrA on Mtb replication status
during infection in vivo, with single bacterium resolution. This will exploit the use of a replication reporter-
expressing STPK phosphoablative PrrA mutant with our integrated imaging system, to delineate how STPK
regulation of PrrA may differentially influence Mtb growth in disparate lesion sublocations, and reveal its
relation to local NO conditions. This project is conceptually innovative in its focus on the connection between
STPKs and TCSs in Mtb, and between Mtb environmental response and replication regulation. By laying the
groundwork for revealing key connecting nodes in these understudied concepts, these studies will provide
insight into facets of Mtb infection biology critical for bacterial colonization success, and open new avenues of
study targeted at understanding and exploiting these vital aspects for therapeutic purposes.

Public health relevance
PROJECT NARRATIVE Differences in Mycobacterium tuberculosis (Mtb) replication status during infection is thought to impact critically on disease and treatment outcome, but how Mtb growth is adaptively coordinated to the local environment remains poorly understood. This proposal seeks to elucidate how serine/threonine protein kinase (STPK) regulation of an essential two-component system (TCS) impacts the adaptive entry of Mtb into a non- replicating state in response to nitric oxide, and its functional consequences for Mtb growth in vivo, with single bacterium resolution in the context of intact tissue architecture. These studies will thus lay a foundation for understanding the connection between STPKs and TCSs, and between Mtb environmental response and replication regulation.